Laser ablation-ICP-TOF mass spectrometer for advanced metallomic/elemental imaging of biomedical samples

With this high-end instrumentation grant (HEI), we are applying for funds to purchase a laser ablation (LA)
inductively coupled plasma (ICP) time of flight (TOF) mass spectrometer (MS) for rapid, high-spatial-resolution,
metallomic/elemental imaging of tissue sections or cells on microscopy slides. We will purchase an ESL
imageBIO266 LA system coupled to a nu Vitesse ICP-TOF-MS instrument, as this combination offers high
sensitivity, large linear range, high spectral resolution, high spatial resolution, and fast imaging speed. We are
opting for a TOF instrument to allow our NIH-funded users multiplex detection of the distribution of several
metals and elements simultaneously from their tissue sections or cells on slides. The ESL imageBIO266–nu
Vitesse LA-ICP-TOF-MS instrument will be placed in the Johns Hopkins Medical Institutions (JHMI) Applied
Imaging Mass Spectrometry (AIMS) Core facility, founded and directed by Dr. Glunde, the principal investigator
of this HEI S10 application, who has 17 years of experience in mass spectrometry imaging. A group of 10 NIH-
funded investigators will comprise a dedicated group of major users, as well as 2 minor users, whose projects
will greatly benefit from the availability of the LA-ICP-TOF MS instrument. Each major user is requesting 7-
12.5% of instrument time. These major users are supported by a total of 16 NIH-funded research grants on
whose research outcomes the ESL imageBIO266–nu Vitesse LA-ICP-TOF-MS instrument would have a
transformative impact. Our user group is multidisciplinary and multi-departmental, spanning the Departments of
Radiology, Physiology, Medicine, Biomedical Engineering, and Biochemistry and Molecular Biology across the
Johns Hopkins School of Medicine, School of Engineering, and School of Public Health. Three department
chairs (Radiology, Physiology, Gastroenterology/Hepatology) and two center directors (Cancer Center, Basic
Biomedical Sciences Institute) across JHMI have committed significant institutional funds towards the
operation of this instrument. The institutional support for this HEI S10 application includes the superb
infrastructure of the JHMI AIMS Core facility, as well as covering running costs for the instrument, and
providing dedicated technical personnel to help users with efficient sample preparation, instrument set-up and
data analysis for their respective LA-ICP-TOF-MS tissue imaging applications. Online booking and billing for
this instrument is available through the iLAB software in the AIMS Core. We are confident that having this
instrument will be essential for advancing basic, translational, and clinical research in areas of great public
health impact, including contrast agent development, image-guided anticancer therapies, regenerative
medicine, infectious disease, host-pathogen interactions, copper metabolism in health and disease, implant
medicine, zinc transporters in diabetes, nephrology, and chemical warfare agent countermeasures. This
instrument has the capabilities of deepening our understanding of important disease processes which will
ultimately lead to new and effective diagnostic tools and treatments.

Public health relevance
This high-end instrumentation grant application requests funds to purchase a laser ablation (LA) inductively coupled plasma (ICP) time of flight (TOF) mass spectrometer (MS) for rapid, high-spatial-resolution, metallomic/ elemental imaging of tissue sections or cells on microscopy slides. We will purchase an ESL imageBIO266 LA system coupled to a nu Vitesse ICP-TOF-MS instrument, which will be installed in the Johns Hopkins Applied Imaging Mass Spectrometry (AIMS) Core to support a diverse group of 10 major users with 16 NIH-funded research grants, as well as 2 minor users. The LA-ICP-TOF-MS instrument will advance their research projects in contrast agent development, image-guided anticancer therapies, regenerative medicine, infectious disease, host-pathogen interactions, copper metabolism in health and disease, implant medicine, zinc transporters in diabetes, nephrology, and chemical warfare agent countermeasures.